Administrative Core

Abstract: The success of the Center for Effective and Accessible Research based Testing for Health (C-EARTH) will depend largely on efficient communication, planning, and synergy among the project, cores, and activities. To accomplish this, the Administrative Core will provide an infrastructure for logistical and scientific oversight, coordination, and integration of C-EARTH, ensuring the synthesis of C-EARTH components and activities towards solutions-oriented translation of findings in support of two themes of the P20 RFA: 1) to investigate the feasibility, acceptability, uptake, and spread of interventions to promote preparedness and adaptation to anticipated health impacts of HEW at individual, community, regional, or national levels; and 2) to explore HEW vulnerabilities in nutritional security to inform solutions. The Administrative Core will serve as a central forum for communication among investigators across the project and cores. We will also carry out career development plans and evaluations for our early-stage faculty and researchers. The core’s activities will ensure effective research capacity by managing the utilization of centralized resources and research infrastructure. The Administrative Core will also oversee a robust data infrastructure and management plan, providing the framework necessary for seamless data management, sharing, and analysis. In particular, the Administrative Core will implement innovative databases and tools for mapping high-resolution apparent temperature at scale. These resources will support the research and core activities throughout C-EARTH. With a strong supportive structure in place, C-EARTH will create a premiere environment for translational research on HEW.

Public health relevance
Extreme heat events are an increasing threat to public health, causing illness, death, and disruptions to food and water supplies. This project will develop and test practical, community based solutions to reduce the health risks of heat stress. By partnering with local organizations and adapting interventions to community needs, this research will provide evidence on effective and scalable strategies to prevent heat-related health problems. The results will guide public health action and policy to better protect US populations from extreme heat now and in the future.